Pathogenic mechanisms of myosin binding protein C missense variants within hypertrophic cardiomyopathy

PROJECT SUMMARY/ABSTRACT
Hypertrophic cardiomyopathy (HCM) is a common genetic disease, affecting ~ 1:500 people, with
substantial clinical burden including heart failure, arrhythmia and sudden cardiac death. The most commonly
affected protein is myosin binding protein C3 (MYBPC3). Defining a MYBPC3 variant as pathogenic enables
clinical prognostication and genetic screening in at-risk relatives. Truncating variants of MYBPC3 cause a
premature stop codon resulting in loss of function. However, missense variants in MYBPC3, often classified as
variants of uncertain significance, are difficult to interpret as proteins may tolerate the substitution of one amino
acid for another. Prior cellular and structural data suggest that pathogenic missense variants may lead to HCM
via two distinct mechanisms. Some pathogenic missense variants normally incorporate into myofibrils and Dr.
Thompson hypothesizes that these variants lead to HCM via inhibition of protein binding. To evaluate this
hypothesis, in aim 1, Dr. Thompson will study alterations in protein binding caused by pathogenic missense
variants using affinity mass spectrometry. Further, she will characterize a patient-derived cellular model and a
knock-in mouse model of the most common pathogenic missense variant predicted to work via this
mechanism, R502W, which accounts for 2.4% of HCM cases. These models will evaluate if HCM phenotypes
can be reversed by expression of wild-type MYBPC3, suggesting a similar targeted therapeutic approach can
be utilized for this common missense variant and truncating variants. Other pathogenic missense variants are
rapidly cleared from the cell, similar to truncating variants, and Dr. Thompson hypothesizes that these variants
lead to HCM via thermodynamic instability. Supporting this hypothesis, her prior computational work
demonstrated that patients with HCM and a MYBPC3 VUS computationally predicted to cause subdomain
misfolding exhibited higher rates of adverse clinical outcomes, similar to patients with HCM and known
MYBPC3 pathogenic variant. In aim 2, she will evaluate if a step-wise experimental approach, which
characterizes variants first in a high-throughput manner within individual subdomains and then within
cardiomyocytes using full-length MYBPC3, will enable accelerated identification of variants which cause
protein misfolding. Taken together, this work should provide novel biologic insight into the pathogenic
mechanism(s) of MYBPC3 missense variants, enable improved clinical prognostication for patients with HCM
and at-risk relatives, and inform personalized targeted therapeutic approaches to treat HCM. This proposal is
distinct from Dr. Thompson’s prior experience in chemical biology and will provide her with valuable training in
disease models of cardiomyopathy, cardiac physiology, and advanced experimental genetics. This work, her
mentorship team, and the training activities described will facilitate Dr. Thompson’s development toward her
ultimate goal of becoming an academic physician-scientist and independent investigator.

Public health relevance
PROJECT NARRATIVE Over 700,00 patients in the United States live with hypertrophic cardiomyopathy, a genetic heart disease. The goal of this project is to define how small changes in a gene, called missense variants, cause hypertrophic cardiomyopathy. This knowledge is critical to developing personalized treatment approaches.